The University of Kansas Cancer Center's- MCA Rural NCORP- extension

PROJECT SUMMARY
The overarching goal for The University of Kansas Cancer Center – Masonic Cancer Alliance Rural
NCORP (KUCC-MCA Rural NCORP) is to enhance rural communities access to clinical trials in cancer
control, prevention, treatment, care delivery clinical trials, and other human research developed and conducted
by NCORP Research Bases. While cancer affects all, rural communities are more at risk than others for poor
outcomes.[1] Inaccessibility of clinical trials due to geographic barriers is an often cited reason for not enrolling
in studies.[2] KUCC is strongly positioned to continue to enhance clinical trial accrual and participation of rural
populations through its leadership of the Masonic Cancer Alliance (MCA) and its cadre of accomplished
investigators with extensive experience working with rural communities and practices. The MCA is KUCC’s
formal outreach network that has partnered with hospitals, cancer centers, and health care providers across
the state of Kansas for close to two decades. The goal of these MCA partnerships is to extend the reach of
clinical research across the KUCC catchment area, with a particular focus on rural communities. The MCA
includes co-administration and support of our state-wide rural primary care practice-based research network,
Kansas Patients and Providers Engaged in Prevention Research (KPPEPR), under the leadership of Dr. K.
Allen Greiner, one of KUCC’s leading cancer prevention investigators. KPPEPR is a network engaging primary
care providers from across Kansas with a longstanding history of supporting cancer prevention and control
research initiatives, 34 who have participated in projects with KUCC in the last five years. The KUCC-MCA
Rural NCORP leverages our over 50-year experience as a SWOG-member, nearly 30-year experience
providing oncology care via telemedicine, 25-year history of successfully conducting research in rural primary
care settings, and 15-year experience opening and running clinical trials within rural health care networks—all
supported by KUCC expertise in partnering with rural oncology and primary care practices to accomplish our
goals. Specifically, the KUCC-MCA Rural NCORP addresses institutional, provider, clinical trial, and patient
barriers to trial accrual, and implemented processes to: 1) Enhance the infrastructure of local cancer centers
and primary care offices to support clinical trial accrual; 2) Expand access to NCORP clinical trials across the
MCA network; 3) Decrease barriers to clinical trial participation for rural patients across Kansas and western
Missouri by providing trial participation opportunities in their home communities; and 4) Leverage KUCC-MCA
expertise for addressing rural cancer clinical trial participation with NCORP grantees.

Public health relevance
PROJECT NARRATIVE Cancer affects all populations, although rural communities are more at risk than others for poor outcomes.[1] Inaccessibility of clinical trials due to geographic barriers is an often-cited reason for not enrolling in studies.[2] KUCC-MCA Rural NCORP will expand access to trials and enhance infrastructure in the local rural community.